Tissue Procurement, Processing and Phenotyping Core

Summary Abstract
The Tissue Procurement, Processing & Phenotyping (TPPP) Core at the University of Colorado Anschutz
Medical Campus is seeking renewed funding to continue its mission of accelerating cutting-edge diabetes
research. As an integral component of the Diabetes Research Center (DRC), the TPPP Core provides
centralized access to high-quality tissues, cells, and state-of-the-art histology services, enabling investigators to
unravel the complexities of diabetes pathogenesis and develop innovative therapies. Building upon a strong
track record of success, the TPPP Core aims to enhance its rodent and human islet and tissue procurement
services, ensuring a reliable supply of well-characterized samples for diverse diabetes research needs. Through
collaborations with leading institutions and programs, such as the Integrated Islet Distribution Program (IIDP)
and the University of Alberta, the core will expand access to valuable human islet samples. Additionally, the
establishment of a streamlined pipeline for human tissue acquisition from the Pathology Department will facilitate
the procurement of pancreatic, adipose, and other relevant tissues. The core's comprehensive histopathology
services, coupled with access to specialized equipment and expert consultation, will empower researchers to
employ cutting-edge methodologies in their studies. Furthermore, the introduction of a state-of-the-art perifusion
analysis service as well as vibratome sectioning for three-dimensional imaging of pancreatic islets will provide
valuable insights into islet and endocrine cell function and differentiation. Recognizing the importance of
collaboration and resource sharing, the TPPP Core will enhance its diabetes-relevant cell line repository and
distribution services. By curating a diverse collection of authenticated cell lines and implementing rigorous quality
control measures, the core will ensure the integrity and reliability of these valuable research tools. The
streamlined distribution process and comprehensive technical support will foster collaboration among DRC
members and accelerate scientific progress. Throughout its operations, the TPPP Core will prioritize training,
education, and mentorship, supporting the next generation of diabetes researchers. By working closely with other
DRC cores and leveraging institutional resources, the TPPP Core will create a synergistic environment that
promotes multidisciplinary research and catalyzes transformative discoveries.

Public health relevance
Narrative The Tissue Procurement, Processing and Phenotyping (TPPP) Core is a vital resource for diabetes researchers, providing access to high-quality human and animal tissues, including pancreatic islets, for their studies. Our expert staff procure and/or isolate and process tissues, create cell lines, and provide histology and perifusion services to help scientists better understand diabetes and develop new treatments. By offering these specialized services and resources, we accelerate diabetes research and support the discovery of new therapies for this prevalent and serious disease.